Adminstration Core

Administrative Core Description: The Administrative Core (directed by Sadis Matalon, PhD) will provide the proper framework that will support, encourage and focus the research efforts of the three projects and of the Exposure Core Facility. This will ensure that all investigators work together as a group, the research efforts remain focused and well integrated and the individual projects generate high quality research to complete their milestones in a timely fashion. Dr. Matalon will also ensure that Dr. Sven Jordt, in spite of the geographical separation, remains well integrated with the rest of the members. In addition the Administrative Core will be responsible for the establishment and maintenance of a Center Website, as specified by the CounterAct Network regulations. Finally, the Director will be in constant touch with NIH personnel and will update the investigators and co-investigators on recent developments.